System for Malignant Lymph Node Identification

Project Summary
Accurate identification of malignant lymph nodes (LNs) is crucial for managing patients with solid cancers,
as treatment planning—whether surgical, radiation, or systemic—depends on knowing the presence and
location of malignant LNs. However, the malignancy status of small or less FDG-avid LNs is often difficult to
determine from standard imaging alone, leading to the overtreatment or unnecessary resection of benign LNs,
which significantly impacts patients' quality of life. To address this challenge, we have developed a high-
performing artificial intelligence (AI)-based LN malignancy classification model. This model has been
successfully implemented in two prospective Phase II clinical trials for head and neck cancer radiation therapy,
allowing clinicians to target malignant LNs while sparing benign ones from therapeutic doses. The results were
highly promising: the risk of solitary elective nodal failure was 0%, and patients experienced significantly
improved quality of life compared to those treated with conventional whole-neck radiation therapy. Recognizing
the growing clinical demand for accurate LN malignancy identification, particularly with the increasing use of
immunotherapy, we have filed a patent application to protect our technology and established DAIgnostx LLC to
support its commercialization. In this Phase I STTR project, we aim to develop the essential components of our
LN malignancy classification system to facilitate widespread clinical adoption. Aim 1 focuses on creating a
localization-guided LN segmentation model to provide accurate LN contours, enabling radiomic feature
extraction critical for classification. Aim 2 involves developing two deployment options for the model: a cloud-
based platform and a standalone desktop application, ensuring broad accessibility and adaptability. Additionally,
we will rigorously evaluate the model’s performance following FDA guidelines with input from RMQ+.
Successful completion of this project will pave the way for regulatory approval and the launch of the first
dedicated product for cervical LNs segmentation and malignancy classification.

Public health relevance
Project Narrative Accurate identification of malignant lymph nodes (LNs) is crucial for planning cancer treatments like surgery, radiation, or systemic therapy, but uncertainties in standard imaging reading often lead to unnecessary treatment of benign LNs and side effects. To address this, we have developed an AI-based LN classification model that has shown excellent performance in clinical trials, improving patient outcomes and quality of life by sparing healthy LNs from overtreatment. In this project, we aim to enhance the model with advanced segmentation tools, deploy it through cloud-based and desktop applications, and rigorously evaluate its performance to prepare for regulatory approval and commercialization.